Dissemination, Implementation, and Effectiveness of an Intervention to Prevent Intimate Partner Violence

Intimate partner violence (IPV) is a widespread and serious public health problem. Globally, 30% of ever-partnered
women experience physical or sexual intimate partner violence (IPV), and over one third of female
homicides are perpetrated by intimate partners. IPV confers negative health and social impacts across the
lifespan, making it critical to understand how to best deploy effective, technology-based interventions to advance
resilience, health and safety for women survivors. Glaring gaps exist in meeting the health and safety needs of
survivors through the formal and informal support system in low-resource settings. Shame, self-blame and lack
of a proactive community response discourage women from disclosing IPV and obtaining the safety planning
and support that can improve resilience, safety, and health. In high-resource settings, an interactive,
personalized safety decision application ("App"), called myPlan has been found effective in increasing use of
helpful safety strategies, perceived support, and safety. Users enter information on: a) relationship health; b)
safety priorities; and c) severity of violence/danger in relationship, and the app generates a personalized safety
plan based on these inputs with links to local resources. Our team recently adapted the myPlan app for its first
LMIC implementation in urban settlements in Nairobi, Kenya where mobile phone access exceeds 94%. The
resulting myPlanKenya recently underwent efficacy evaluation via randomized controlled trial with positive
preliminary intervention effects on survivor’s safety preparedness and resilience. Our stakeholders have
identified two distinct organizational types for app dissemination and implementation: the formal sectors often
tasked with IPV response, and the community-based, informal networks where women often turn first for support.
Therefore, the objective of the 5-year study is to: 1) disseminate the myPlanKenya app through formal systems
(i.e., health, education, justice) and informal, community-based networks in Nairobi, Kenya, and document and
compare reach and adoption, 2) compare the nature and intensity of myPlanKenya implementation at 6-month
follow-up and maintenance at 12-month follow-up by organizational characteristics (formal vs. informal,
organizational readiness for IPV response and IPV-related attitudes), and 3) evaluate the effectiveness of
myPlanKenya referral on resilience, health and safety among a cohort of women referred to the myPlanKenya
app based on disclosure of IPV or assessed to have IPV related risks. Our study will address the paucity of
evidence that exists on dissemination pathways for effective health and safety interventions to prevent and
respond to IPV. Our study is comprehensive in informing both processes and impacts of app dissemination, and
spanning the full pathway from dissemination to effectiveness. Findings will inform optimization of dissemination
and implementation strategies for IPV prevention and response in areas of greatest need.

Public health relevance
PUBLIC HEALTH RELEVANCE: The study advances National Institute of Child Health and Human Development (NICHD) dissemination and implementation research priorities of community-based participatory studies to engage communities in prevention of violence and injury, improve quality of life and functional status after violence, and foster resilience. Findings will advance the science for large-scale implementation of technology-based safety interventions in settings of greatest need.